Dissecting the Protective Role of Cardiac Hsp90ß Ablation/Inhibition

PROJECT SUMMARY
Dysfunctions are observed at multiple cellular and subcellular levels in heart diseases. However, current
therapeutics are designed to tackle a single subcellular disease mechanism or molecular target. Our long term
goal is to develop strategies to correct several pathways simultaneously, which can ultimately improve clinical
outcomes. In this regard, Hsp90β is a desirable target, as it can affect many downstream signaling pathways.
However, the role of Hsp90β in cardiac function is not clear due to a lack of viable ablation animal models. To
this end, we generated a cardiac-specific inducible Hsp90β knockout (Hsp90βCM-/-) mice and to our surprise,
their hearts were protected from myocardial infarction induced by ischemia/reperfusion (I/R) injury, which is
paradoxical to its known pro-survival role. Furthermore, this protection is specific to Hsp90β as Hsp90αCM-/- hearts
were not protected. These findings suggest that specific Hsp90β inhibition may be a good therapeutic strategy
for I/R injury. Thus, our main goal in this application is to carefully examine the protective role of cardiac Hsp90β
and dissect the Hsp90β specific interactome to identify the underlying mechanisms.
Based on our previous publications and existing pilot data, we hypothesize that removal of cardiac Hsp90β
confers cardioprotection, partly by preserving mitochondrial membrane integrity. In this R01 application, we will
address this hypothesis in three independent but related aims. In Aim 1, we will thoroughly examine if our new
Hsp90βCM-/- hearts are protected from ischemic insult at young (3 months) or old (12 months) age. We will
examine the potential pro-death role of cardiac Hsp90β in sensitizing the opening of mitochondrial permeability
transition pore and necrotic cell death upon I/R injury. In Aim 2, with our previous knowledge on the role of
Hsp90β/HCLS1-associated protein X-1 (HAX-1) interaction in mitochondrial membrane protection, we will map
out the minimal binding domains and test the feasibility of using this mimetic peptide to confer protection only in
the mitochondria. In Aim 3, we will furthermore examine the effect of Hsp90 ablation in chronic cardiac diseases.
We also aim to identify the gene dosage effect of Hsp90 on cardiac function by using Hsp90αCM-/-, Hsp90αCM-/-
βCM+/- and Hsp90αCM+/-βCM-/- mice as well. We will perform interactome analysis for both Hsp90α and Hsp90β in
human patient hearts to identify isoform-specific interactome and their shift during cardiac diseases. Lastly, we
have developed a prediction tool for binding interface for Hsp90 substrates. We will combine the use of this
prediction tool and mimetic peptide to identify novel Hsp90 isoform specific binding partners in the heart. By the
completion of this study, we expect to gain important insight on how to specifically study particular Hsp90α or
Hsp90β complex and evaluate the potential therapeutic application in the future.

Public health relevance
PROJECT NARRATIVE Hsp90β is an essential chaperone that maintain cellular function both under basal and stress conditions, but we surprisingly found that cardiac-specific ablation showed protective effects, which is paradoxical to its known pro-survival role. In this project, we will characterize the Hsp90β ablation mice and explore the effects of Hsp90β ablation or inhibition during ischemia/reperfusion injury. Using inducible Hsp90 ablation mice, induced pluripotent stem cell platform, peptide engineering, tissue engineering, machine learning and multi-omics approaches, we aim to uncover the role of Hsp90 (both isoforms) in heart function.